Genetic basis of circadian rhythms and sleep disorders

Project Abstract
Our long-term goal is to understand the genetic and molecular organization of circadian rhythms in mammalian
models and humans, and the molecular mechanisms underpinning disorders of circadian rhythms and sleep. In
doing so, we will provide important insights for treating a wide variety of diseases in which sleep disorders are
major causes, symptoms, or comorbidities. We are pursuing three research areas under this common goal. 1)
The genetic basis of human chronotypes and sleep disorders: Despite a clear causal link between genetic
polymorphism in clock genes and sleep disorders, systematic investigation of pathogenic mutations in human
clock genes has not been conducted for two reasons: The first is the abundance of natural genetic
polymorphisms. There are thousands of known polymorphisms in major clock genes, a subset of which may
affect chronotypes and sleep disorders. The second is the historical reliance on rodent models for functional
assessment, which are time- and resource-intensive. To address this gap, we developed a cell-based in vivo-
like platform that allows us to screen and characterize dozens of hypothesis-driven mutations along with
natural human mutations in a cost- and labor-effective manner. Using our system, we identified novel
mechanisms and mutations that can cause dramatically altered rhythms and sleep cycles. During the course of
analyzing dozens of mutations in pacemaker clock genes, we found common themes that allow us to identify
potential pathogenic mutations and predict their phenotypes. 2) The molecular link between the circadian
clock and sleep homeostasis: Sleep is regulated by two distinct but interconnected mechanisms: sleep
homeostasis and the circadian clock. Optimal sleep quality requires alignment of these two sleep-regulating
pathways, and disruptions in either one can lead to sleep disorders. However, the mechanistic links between
the circadian clock and sleep homeostasis have been largely unexplored. Recently, we serendipitously found
that a Per2-driven clock in Per1 knockout (KO) mice behaves very differently from a wild-type (wt) clock and
from a Per1-driven clock in Per2 KO mice when they are perturbed by long light pulses. Per1 KO mice showed
dramatic phase shifting, called type 0 resetting, while wt and Per2 KO mice exhibited weak (type 1) resetting.
Per1 KO mice always reset to CT12, the time of activity onset or lowest sleep pressure, regardless of when the
light pulses were given. The Per2-driven oscillator seems to measure or regulate temporal sleep pressure, in
addition to driving circadian rhythms. We propose to continue this line of investigation to unravel the molecular
link between the clock and sleep homeostasis. 3) Identification of novel clock genes: We engineered a
human cell line with a functioning circadian clock (U2OS) to express fluorescent protein-fused clock proteins
from endogenous loci and thus report expression of endogenous clock genes. With powerful CRISPR lentiviral
libraries targeting all human genes, we will identify novel candidate genes that affect expression of the reporter
clock genes by FACS and high-throughput sequencing.

Public health relevance
Project Narrative The circadian clock is the master regulator of circadian rhythms including sleep, and our general physiology, behavior, and health are profoundly impacted by circadian rhythms—and by their disruption. Our research focuses on the genetic and molecular underpinnings of the clock and of circadian disorders, and thus is directly relevant not only to NIGMS but also the overarching mission of NIH, reduced illness and better health.